TASK A109: MOUSE MODEL FOR TESTING OF INFLUENZA VACCINE CANDIDATES AND VACCINATION STRATEGIES AGAINST INFLUENZA VIRUS INFECTION

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.